The Impact of COVID-19 and Social Distancing on Cancer-Related Behaviors

Given the wide variability in communication and restrictions across communities in the U.S. in response to the COVID-19 pandemic, the extent to which people across the country are changing their behaviors to mitigate risk of transmission is unknown. Furthermore, it is difficult to anticipate how changing behaviors in response to COVID-19 could impact cancerrelated behaviors and risk factors; exercising, drinking, smoking, diet and stress could be profoundly impacted as a result of social distancing and self-isolation. Furthermore, different populations may be impacted in very different ways. For example, Iowa is among the handful of predominantly rural states that have not yet implemented a statewide shelter in place order, citing lower risk of infection in rural areas. Yet in this first week of April, the case rate in rural areas has more than doubled from one week prior, and widespread testing is not available to assess the true extent of the case count. It has also been reported that in rural areas without reliable internet access, adults are struggling to work remotely, and children are having to get school assignments delivered to their door.1 Furthermore, rural communities may have diminished access to health information, healthcare services, grocery stores and pharmacies. As a multicenter group of cancer researchers already invested deeply in understanding and improving health outcomes in our catchment areas, we propose to rapidly deploy surveys containing a standard set of core questions to populations across the U.S. The overall objective of our collaborative effort is to assess how differences in demographics (rurality, age, gender, race, educational attainment) will impact engagement in cancer preventive behaviors (e.g., tobacco cessation) and cancer management/survivorship behaviors (e.g., adherence to treatment, adherence to surveillance) in the context of COVID-19 environmental constraints (e.g., social distancing, employment, mental health, etc.) among the general adult populations, cancer patients, and cancer survivors in Iowa.

Public health relevance
The Cancer Center Support Grant supports the infrastructure of the Holden Comprehensive Cancer Center. This infrastructure allows the Center to foster excellence in research across a broad spectrum of scientific areas relevant to cancer, and translate those advances to the clinic with the goal of reducing the morbidity and mortality of cancer.